Mechanotransduction regulation of cellular metabolism in pulmonary fibrosis

PROJECT SUMMARY
Idiopathic Pulmonary Fibrosis (IPF) is a progressive scarring disease with limited therapeutic options. Fibrotic
lung diseases are characterized by an accumulation of excess extracellular matrix (ECM), contributing to the
destruction of lung architecture, inability to perform gas exchange, and even death. My mentor published
pioneering work that IPF patients have abnormally high levels of lactate in their lungs. Lactate in turn decreases
the local pH, which activates latent TGFβ, resulting in a pro-fibrotic feed-forward loop that drives fibrosis and
dysregulated metabolism. We and others have demonstrated that increased tissue stiffness in lung fibrosis also
drives fibroblast differentiation, expression of matrix proteins, and cross-linking, resulting in further increases in
tissue stiffness. While tissue stiffness and altered lactate metabolism are independently recognized as
pathogenic pathways and potential therapeutic targets, I have now identified the mechanoreceptor Piezo2 as a
potential link between altered tissue mechanics and aberrant metabolism. In this revised project application, I
will use patient-derived non-fibrotic and IPF lung fibroblasts to characterize the mechanism by which Piezo2
drives metabolic adaptations in response to increased matrix stiffness, and how these metabolic adaptations
contribute to a feed-forward loop that drives fibrosis. I will also use well-characterized pre-clinical mouse models
of pulmonary fibrosis to investigate the role of Piezo2 in vivo using genetic knockdown and pharmaceutical
inhibition approaches. To further support the clinical relevance of my results, the metabolic adaptations identified
in the cell culture and mouse models will be compared with my new evidence of metabolic disruptions in the
lungs of IPF patients obtained by metabolomics analysis of exhaled breath condensate. This project will support
my career goal to transition to a tenure-track faculty position as an independent investigator. To complete my
technical training needs for this project, I will work with my co-mentor Dr. L. Ashley Cowart to participate in
extensive hands-on training in metabolomics data analysis, as well as attend training courses at the highly
regarded West Coast Metabolomics Center at UC Davis. My co-mentor Dr. Patricia Sime will guide me in my
professional development as an independent scientist by providing additional training opportunities in
translational research, grant writing and scientific communication, lab management and administration, teaching,
and mentoring others. I have established a strong mentor committee and strong relationships with internal and
external collaborators. Virginia Commonwealth University is a highly productive scientific environment and is
very supportive of my development as an independent scientist. My training and research experience under this
career development award will yield novel insights into the pathogenic mechanisms of pulmonary fibrosis, giving
me foundational skills and my own research project to carry me into independence.

Public health relevance
PROJECT NARRATIVE Idiopathic Pulmonary Fibrosis (IPF) is a devastating, progressive scarring disease of the lung that is driven by multiple mechanisms. Tissue stiffening and aberrant metabolism have been identified as critical pathways contributing to progression and I have now identified potential cross-talk between these two mechanisms. Using clinically relevant patient derived cell lines and animal models I will investigate the mechanism linking stiffness and metabolism, as well as test the efficacy of targeting mechanotransduction to reduce fibrosis development and limit metabolic changes.